Development of compound RUEC2-118, a novel partial GABAAR positive modulator, a fast-acting treatment for general anxiety and panic disorder, to prevent opioid and benzodiazepine overdose fatalities.

Opioid use disorder (OUD) is highly prevalent among individuals with diagnosed anxiety disorders with more
than 60% of individuals with OUD reporting a lifetime anxiety disorder. Co-occurring anxiety is linked to earlier
and more rapid progression into OUD, poorer treatment outcomes, and high probability of co-use of other
substances, particularly benzodiazepines (BZDs). BZDs are currently the standard of care treatment for fast-
acting relief for general anxiety and panic disorder. Although highly effective in the short-term, BZDs represent
a major, but often overlooked contributor to the opioid overdose epidemic. BZDs are involved in an estimated
12,000 overdose fatalities each year in the US, largely due to the concomitant use with other CNS depressants,
such as opioids3 In fact, more than 90% of benzodiazepine overdose fatalities involve opioids, up to 30% opioid
overdoses involve BZDs, and opioid overdose rates are directly linked to BZD prescribing rates per state. With
a lack of safer alternatives that can offer comparable efficacy, BZD market predictions indicate their use will
remain steady or increase globally.11 Thus, there is an urgent need to develop safe and comparably effective
alternatives to BZDs for those with OUD. Previous drug discovery efforts to improve safety of GABAAR PAMs
focused on elimination of sedative and addictive properties, which proved difficult to translate in clinical trials,
and drug discovery efforts have waned. However, there is substantial evidence that synthetic flavone derived
partial GABAAR PAMs can provide fast-acting anxiolytic activity with improved safety profiles over BZD and
imidazobenzodiazepine (iBZD) derivatives. This inspired us to design derivatives of promising synthetic and
natural GABAAR active flavones, leading to the discovery of RU-EC2-118, a partial GABAAR PAM with an EC50
of 136 nM and 126 nM at α1β3γ2 and α2β3γ2 GABAAR subtypes. While further investigation is necessary, our
preliminary results, in vivo studies in rat models, strongly support the potential for the mechanism of RUEC2-118
to provide effective fast-acting anxiolytic activity and a safer profile with co-use with other CNS-depressing
substances. Specific Aim 1 includes anxiolytic efficacy studies in mice, as measured by elevated plus maze with
RUEC2-118 (5,10, 15 mg/kg PO) and alprazolam (0.5 mg/kg PO). Specific Aim 2 includes respiratory depression
studies in mice with RUEC2-118 (15 mg/kg IP), alprazolam (0.5 mg/kg IP) with and without concurrent fentanyl
(0.25 mg/kg) administration. Specific Aims 1 and 2 are intended to test the feasibility of the mechanism of
RUEC2-118 to provide effective fast-acting anxiolytic activity without enhancing opioid-induced respiratory
depression. Specific Aim 3 is intended to test the desirability of our innovation and includes enrollment in the
NIH I-Corps program and scheduling of a pre-IND meeting with the FDA. The successful translation of our
research will groundwork for the development of a safe and effective anxiolytic for individuals with OUD that can
prevent future opioid and benzodiazepine overdose fatalities.

Public health relevance
Project Narrative Unlike benzodiazepines (full GABAAR PAMs), which are the current standard for fast-acting treatment of general anxiety and panic disorder and are involved in more than 12,000 overdose fatalities each year in the US alone, our novel partial GABAAR PAM will help prescribers who want to ensure the safety of prescribed medications in individuals with history of OUD, who are at high risk for misuse. Even if co-used with opioids, our compound is hypothesized to reduce the overdose risks and to prevent polysubstance overdose fatalities.